Sieve based full likelihood approach for the Cox proportional hazards model with applications to immunotherapies trials

In clinical studies, the time-to-event outcomes are widely used to evaluate a new treatment
efficacy. When complete randomization is not possible or successful the Cox proportional
hazards model can be used to adjust for the confounding effects and to increase statistical
power. Phase II studies usually have relatively small number, so the survival analysis results are
not very reliable or do not have enough power to detect a positive result of the experimental
treatment. This project aims to provide better survival analysis results compared to existing
methods for small sample studies. Sieve method has becoming a popular approach in
survival analysis, we propose to use the sieve maximum likelihood estimations to improve
survival analysis results for small studies and provide corresponding computing tools for
public use.

Public health relevance
The Cox regression is the important method for assessing the effects of different factors on the time-to-event outcomes. The project will propose novel approaches to improve the Cox regression estimation. The computing tools based on the proposed methods will improve the scientific rigor and the reporting of findings for clinical studies with time-to-event outcomes.